Music as an autobiographical memory cue across the lifespan

With steady growth of the aging population and associated pathologies such as Alzheimer’s disease, the need
for understanding age-related changes in cognition is pertinent and critical. One important aspect of cognition
that declines in both healthy and pathological aging is the ability to recall episodically-detailed autobiographical
memories. One potential way to cue vivid and detailed autobiographical memories is through the use of
musical cues. However, whether music is a particularly effective memory cue for older adults, and the
mechanisms underlying such music-induced reminiscence, are currently unknown. The primary goal of the
proposed research program is to determine whether music improves autobiographical memory retrieval in
healthy aging, and whether such music-induced remembering leads to increased positive emotions. The
studies proposed here are designed around a novel framework which proposes that music is a particularly
effective memory cue for evoking memories involuntarily – that is, music evokes memories that spontaneously
come to mind with little cognitive effort. These memories are in contrast to memories retrieved in a voluntary
manner, which may require cognitive capacities that are degraded over the course of the lifespan. Aim 1 will
investigate autobiographical memory retrieval in response to musical and other sensory cues across the
lifespan. These studies will test the prediction that music-evoked memories will be relatively preserved in
healthy aging, and will be evoked in a more involuntary manner, as compared to memories evoked by other
sensory cues. Aim 2 will investigate the emotional outcomes of such music-induced reminiscence in older
adults. We predict that memory-evoking music will induce prolonged positive changes in mood, as compared
to music that does not evoke memories. Overall, this work aims to develop an understanding of how music
affects autobiographical memory and emotional responses across the lifespan. The results of this work could
form the basis for future interventions which use music to improve cognitive functioning, mood, and wellbeing
in older adults.

Public health relevance
Difficulties with autobiographical memory retrieval are common in healthy aging. The goal of this project is to investigate the use of music as an autobiographical memory cue across the lifespan, and whether such music- induced reminiscence leads to increased feelings of positive emotions. Better understanding of how music evokes autobiographical memories and associated emotions can inform the development of effective music- based interventions to improve cognition, affect, and wellbeing in older adults.